Role of RNAs in post-stroke brain damage

Cerebral ischemia significantly alters the expression and/or function of transcriptional and translational
mechanisms including various classes of noncoding RNAs, epigenetics and epitranscriptomics. My
research in the past 20 years evaluated these mechanisms that are central in promoting either
secondary brain damage or recovery after stroke with a goal to design novel therapies. In the 7 years,
I will focus on studying the role of various RNAs in promoting post-stroke brain damage. The goal is to
understand the mechanisms as well as identifying new therapeutic targets to minimize the secondary
brain damage and to promote functional recovery after stroke. In this R35, I propose 4 projects. Project
1: In a currently funded RO1 grant we are evaluating the functional significance of an epigenetic
modification called DNA hydroxymethylation (5hmC). Our studies so far showed that stroke leads to
induction of 5hmC in many prosurvival genes that induces their expression. We intriguingly observed
that many lncRNA induced after stroke also show increased 5hmC levels. In this project, we will
continue the studies to understand the significance of 5hmC induction in lncRNAs to post-stroke
functional outcomes. Project 2: RNAs can be tagged by >150 distinct chemical modifications, which
are collectively defined as epitranscriptomic modifications that form an additional layer of post-
transcriptional gene regulation. Among them, methylation of the adenosine at N6-position (N6-
methyladenosine; m6A) is the most abundant modification in the brain. Our studies show that focal
ischemia downregulates m6A demethylase FTO leading to increased abundance of m6A-tagged
mRNAs. Many of these are inflammatory and apoptotic. Furthermore, activation of FTO promotes RNA
demethylation and neuroprotection. We will use molecular tools to evaluate the functional significance
and mechanisms of increased m6A methylation of RNAs in brain damage after stroke. Project 3: RNAs
can also undergo the epitranscriptomics modification of glycation and the neural glycoRNAs interact
with microglial Siglec receptors to dampen inflammation following CNS insults. We will study the
significance of glycoRNAs and the mechanism of action in brain after stroke. Project 4: Various classes
of RNAs collaborate in their actions. We particularly observed that circular RNAs interact with lncRNAs
to modulate mRNAs and microRNAs. We will analyze the role of RNA networks in relation to ischemic
brain damage using 2 examples. Project 4A: The first one is the interaction of a circRNA (circPUM1)
with a lncRNA (NORAD) to control a mRNA that codes an RNA binding protein (Pum1) and a mRNA
that codes BNIP2. Project 4B: An ongoing RO1 is studying the role of miR-7 in controlling -Synuclein
in post-stroke brain. Although mature miR-7 levels decrease after stroke, levels of premiR-7a and 7b
are not altered. As circRNA CDR1as binds and stabilizes miR-7, we are planning to study the interactive
role of this CDR1as-miR-7--Synuclein in mediating post-ischemic brain damage. Overall, the above
projects are all focused to evaluate the significance of various RNAs with a goal to find new
mechanisms and new targets to design future molecular therapies to curtail post-stroke brain damage.

Public health relevance
Project Narrative Studying the functional role of various classes of RNAs can lead to better handling of the downstream pathologic events to control the ischemic brain damage. The present project is an effort to study the interaction of noncoding RNAs, epigenetics and epitranscriptomics in modulating secondary brain damage after stroke. The long-term goal is to identify novel targets amenable for therapeutic development to promote recovery after stroke